Modulating the PD-1/PD-L1 checkpoint to promote antitumor activity of HER2 CAR T cells in patients with sarcoma

PROJECT SUMMARY/ABSTRACT
Immunotherapy has shown limited efficacy against pediatric sarcoma. In our recently completed phase I study,
infusion of HER2-targeted chimeric antigen receptor T cells (CAR-T) was safe and showed encouraging
indicators of antitumor activity, including three durable complete responses. The key observations from this study
are: (1) lymphodepletion promotes CAR-T expansion but only marginally improves persistence, (2) adoptively
transferred CAR-T are susceptible to immune inhibition, and (3) antigen downregulation/loss is associated with
disease relapse. While the literature is lacking on immune inhibitory mechanisms and tumor adaptations in
sarcoma, our findings are in line with observations made by others in early clinical and pre-clinical studies of
cellular therapy for solid tumors. Our long-term goal is to develop new approaches that capitalize on expected
tumor defenses which may be key to unleashing the potential of CAR-T against sarcomas and other solid tumors.
Therapeutic approaches that integrate strategies to address these compensatory mechanisms up front may
mitigate downstream tumor escape and relapse. The objective of this project is to conduct prospective clinical
testing of HER2 CAR-T in combination with PD-1/PD-L1 checkpoint disruption strategies in a disease-specific
cohort. The central hypothesis is that the combination immunotherapy will promote immune infiltration, remodel
the tumor microenvironment, alleviate CAR-T dysfunction, and thereby improve antitumor responses. Our
specific aims will test the following hypotheses: (Aim 1) The combination of anti-PD-1 antibody and HER2 CAR-
T administered after lymphodepletion is safe in patients with sarcoma, will improve CAR-T kinetics, and will elicit
antitumor responses; (Aim 2) Cellular and serum-based studies in treated patients will help identify biomarkers
of toxicity and response; and (Aim 3) Engineering CAR-T to positively transform the PD-1/PD-L1 interaction in
the tumor microenvironment will potentiate antitumor effects of the cellular product while incorporating design
attributes to enhance its safety . We will evaluate Aims 1 and 2 through implementation of a phase I study of
autologous HER2 CAR-T and anti-PD-1 antibody after cyclophosphamide and fludarabine lymphodepletion in
patients with sarcoma (HEROS 3.0 clinical trial). In Aim 3, we will develop an investigational new drug (IND) for
HER2 CAR-T co-expressing a PD-1 checkpoint reversal receptor (CPR). At the conclusion of the project, we will
understand if CAR-T can be safely administered with immune checkpoint inhibition to improve treatment
outcomes for children and young adults with sarcoma. The significance of these contributions are: (1)
establishing the clinical utility of combination immunotherapy for sarcoma, (2) potentially identifying “modifiable”
patient- and treatment-related factors to guide future improvements to CAR-T therapy, and (3) enabling clinical
testing of an innovative CAR-T platform. This knowledge is critical to advancing the field, as recurrent or
refractory sarcomas remain largely incurable.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because average years of life lost to pediatric sarcomas has remained unacceptably low and unchanged over the last three decades, with less than 30% overall survival in those with relapsed disease. Immunotherapy offers a potential alternative or synergistic approach to chemotherapy; at the conclusion of this study, we will understand if manipulating immune inhibitory signals in the tumor microenvironment using immune check point inhibition safely augments the clinical efficacy of chimeric antigen receptor T cells, and we will prospectively identify factors that improve patient selection and guide interventions. These findings will contribute to opening research avenues into both the feasibility and biology of combination immunotherapy approaches, akin to the historical emergence of multi-drug chemotherapy regimens to improve cancer outcomes.